Observational Dietary Intake and Dietary Behvaiors among Adults Living with Sickle Cell Disease

In December, 2021 the protocol was approved by the NIH Intramural Review Board (IRB). Recruitment for the study commenced in May, 2022. Study procedures completed to date include the enrollment and informed consent of 17 participants and completion of all study procedures by 10 participants as of August 2022. Study participants were recruited from NIH Intramural studies, the Office of Patient Recruitment, as well as from non-NIH hematology providers. Two non-data manuscripts related to the studys research objectives have been prepared for submission to peer-reviewed journals. The study plans to continue recruitment until July, 2023. Dissemination of both quantitative and qualitative empiric data is planned to commence in 2023.

Resources used to date for the study included electronic consent processes, outpatient clinic staff at the NIH Clinical Center, telehealth visit procedures, and the utilization of BTRIS and REDCap services for data management.